Investigating a neuroprotective role of GBA in astrocytes

A key feature of Parkinson’s disease (PD) is abnormal protein aggregation within neurons in the brain.
These neuronal protein aggregates spread throughout the nervous system as PD progresses, but how this
occurs remains unclear. Recent work suggests that astrocytes, which support neuronal function by providing
energy and protection from cellular stressors, may also have a neuroprotective role in PD and other
neurodegenerative diseases. This proposal investigates a potential new role for the gene GBA, a common
genetic risk factor for PD that is also associated with faster disease progression. While most studies of GBA
focus exclusively on its role in neurons, we will test whether GBA is required in astrocytes to uptake and
degrade neuronal-derived proteins in the extracellular matrix to reduce propagation of pathogenic neuronal
protein aggregates.
Our recent work using our Drosophila GBA deficient model (GBAdel) of PD indicates that exosomes are an
important vehicle mediating the spread of protein aggregation. GBA deficiency dysregulates exosome formation,
fusion, and/or content. Surprisingly, we found that glial expression of wildtype GBA can reduce protein
aggregation present in GBAdel fly brains. To further investigate a possible neuroprotective role for GBA in
astrocytes, we will use cultured neurons and astrocytes differentiated from human induced pluripotent stem cells
generated from PD patients carrying GBA mutations. Unrelated healthy age- and sex-matched control and
isogenic controls generated by CRISPR/Cas9 reversion of the GBA mutation to wildtype will be used as controls.
We will first determine whether GBA is important for astrocyte uptake and processing of neuronal-derived EVs
by examining GBA PD versus control astrocyte uptake and intracellular trafficking of neuronal EVs containing
synuclein-GFP fusion protein. We will then test whether GBA has a neuroprotective role in astrocytes by co-
culturing GBA PD or control astrocytes with GBA PD or control neurons and examine protein aggregation,
endolysosomal trafficking and cell survival in both cell types. The results from this study could uncover new
therapeutic targets to enhance the neuroprotective function of astrocytes, leading to treatments that could slow
or halt the progression of PD and other neurodegenerative diseases characterized by protein aggregates.

Public health relevance
Project Narrative GBA mutations are not only the most prevalent genetic risk factor for Parkinson’s disease (PD), but also accelerate disease progression. Our work and others’ have recently implicated GBA in extracellular vesicle (EV) regulation, suggesting a novel non-cell autonomous mechanism for GBA in accelerating propagation of Lewy bodies. This project investigates whether GBA mutations accelerate PD pathogenesis by impairing astrocyte-neuron neuroprotective interactions mediated by EVs using an innovative co-culturing system of human neurons and astrocytes derived from iPSCs from PD patients carrying pathogenic GBA mutations.